Resilience to Adult Revictimization Among Survivors of Child and Adolescent Sexual Assault

Project Summary
Researchers have made considerable progress in understanding mechanisms responsible for adult
revictimization. Although a variety of factors have been implicated, posttraumatic stress symptoms stemming
from child or adolescent sexual assault (CASA) are an especially prominent risk factor for later revictimization.
By contrast, little attention has been given to factors that may buffer associations between CASA and adult
revictimization. Recent research identifies high levels of social support as a key interpersonal factor that may
buffer relations between CASA and adult revictimization. Other literature suggests that certain intrapersonal
processes may also buffer against the ill effects of trauma. In particular, gratitude, self-compassion, and
optimism are constructs known to promote resilience in response to adversity. Drawing on these findings, our
central hypothesis is that social support and these key psychological strengths will, independently and
together, moderate relations between PTSD symptoms and adult revictimization among survivors of CASA. To
test this hypothesis, a sample of 250 college women with a history of CASA will complete self-report
questionnaires assessing symptoms of PTSD linked to CASA, social support, psychological strengths (i.e.,
gratitude, self-compassion, and optimism), and occurrences of sexual revictimization at three time points over
the course of 12 months. This methodology will permit a prospective examination of social support and
psychological strengths as possible buffers against subsequent sexual revictimization. Findings from this study
are expected to clarify key interpersonal and intrapersonal processes that may promote resilience to
revictimization among CASA survivors. These results may inform the development of effective intervention
strategies to reduce CASA-related PTSD and adult revictimization.

Public health relevance
Project Narrative Adult revictimization resulting from child or adolescent sexual assault (CASA) and associated symptoms of posttraumatic stress represent a significant public health problem, often leading to persistent physical and psychological difficulties experienced by female victims that result in enormous healthcare costs and loss of productivity. Research examining the role of both interpersonal and intrapersonal processes in reducing the risk of revictimization can inform the development of effective intervention strategies aimed at helping this population. Consistent with this goal, the current project will examine the role of social support and three psychological strengths—gratitude, self-compassion, and optimism—in promoting resilience to revictimization among female survivors of CASA.